Peripheral nervous system aging

Summary
Aging alters the function of every organ. An inherent limitation to our understanding of aging is
the complexity of the aging process. Thus, fundamental questions remain entirely unanswered:
Are there mechanisms that coordinate organ function and how do they deteriorate with age?
Could such mechanisms be restored to promote longevity? Previous work has revealed how
immune cells and blood factors can impact organ aging and orchestrate organ communication.
However, it remains entirely mysterious whether other synchronization systems could regulate
organ aging. We are interested in the peripheral nervous system, which connects the brain to all
organs, and whether it could coordinate the tempo of aging. This is a challenging problem
because aging is a complex process and organ innervation by the peripheral nervous system is
extraordinarily diverse.
Our lab has recently generated paradigm-shifting methods to study complex aging biology.
We have developed machine learning approaches coupled to spatial transcriptomics to determine
the age of multiple cell types and to understand the impact cells have on neighboring cells within
an organ. In addition, we have recently developed the first in vivo screens for brain aging in mice.
Finally, we have established a new vertebrate model system, the African killifish, to perform aging
studies at scale. The time is right to leverage these cutting-edge tools and develop new ones to
understand how organ innervation responds to aging and to identify targeted approaches to boost
the peripheral nervous system to “re-set” organ function and coordination during aging.
We are interested in the following high-risk, high-reward questions: What are the age-
dependent changes in the peripheral nervous system and how do they differ in diverse organs?
How is the activity of peripheral neurons influenced by environmental stimuli that impact
longevity? Is the peripheral nervous system functionally implicated in organ aging and how does
it coordinate organ aging? Could the tempo of organ aging be “re-set” by restoring organ
innervation?
Addressing these questions has the potential to revolutionize how we think about aging
and could lead to entirely new strategies to counter aging and diseases. More generally, solutions
to this challenge could be broadly applied to other biological phenomena where time and organ
coordination are critical.

Public health relevance
Narrative We are interested in the peripheral nervous system, which connects the brain to all organs, and how it could set the tempo of aging. Understanding the role of peripheral organ innervation during aging is important because it could lead to entirely new strategies to counter aging and diseases. Solutions to this question could also be broadly applied to other biological phenomena where time and organ coordination are critical.